BCCMA: Recovery of Aged Muscle After Disuse Atrophy (REMEDY): Exercise and Monitoring with Post-Hospitalization Muscle Atrophy to Sustain Intrinsic Capacity and Strength (EMPHASIS)

The EMPHASIS arm of the overarching BCCMA REMEDY Project is dedicated to tackling the notable concern
of muscle atrophy following hospitalization. This condition, known as disuse muscle atrophy, poses a substantial
challenge to the health and well-being of individuals, particularly those hospitalized. To tackle this problem, the
project focuses on a specific group of individuals particularly vulnerable to this issue: Veterans with chronic
kidney disease (CKD). This disease affects a substantial population of over 500,000 Veterans, leading to a
progressive decline in mobility, unfavorable changes in lean body mass, and heightened hospitalization rates.
To comprehensively address this concern, the project intends to develop and implement assessment and
intervention strategies tailored to the target cohort's needs. By concentrating on Veterans with CKD, the project
seeks to generate approaches that can be widely applied to address muscle atrophy among individuals with
similar conditions. To achieve this, the project will commence by establishing a baseline cohort of Veterans with
Stage 3 and 4 CKD at two distinct Veterans Affairs sites located in Denver and Baltimore. Upon enrollment, the
Veterans muscle health will be assessed, encompassing various dimensions such as strength, lean body mass,
muscle composition, mobility, and intrinsic capacity. This comprehensive evaluation will provide a snapshot of
their pre-hospitalization muscle health. Subsequently, the enrolled Veterans will be closely monitored for at least
two years. The project's approach involves conducting regular assessments of their muscle health every six
months. Additionally, the participating Veterans will provide information about their strength and functional status
every quarter, facilitated through a smartphone application. A particularly noteworthy aspect of the project is its
inclusion of a pragmatic rehabilitation intervention trial. Veterans who experience hospitalization during the study
will have the opportunity to participate in this trial. They will be assigned to either a supervised flywheel
strengthening exercise group or receive usual care over 16 weeks. This intervention trial aims to assess the
effectiveness of targeted exercise in mitigating the effects of disuse muscle atrophy post-hospitalization. The
overarching design of the project encompasses three main objectives. Aim 1: Identify effective muscle
assessment sites for disuse muscle atrophy. Aim 2: Assess if standardized intrinsic capacity and physical
resilience assessments predict hospital outcomes. We anticipate that physical resilience scores will improve
hospitalization and strength outcomes predictions. Aim 3: Evaluate a supervised flywheel exercise program
against usual care. Both groups are expected to improve, with the supervised group having better results. The
project seeks to establish standardized measures for clinical trials. These insights will inform the development
of standardized measures for future clinical trials. In conclusion, the EMPHASIS arm of the REMEDY Project
represents a comprehensive and well-structured initiative to address post-hospitalization disuse muscle atrophy
among Veterans with CDK. Through its multi-faceted approach encompassing cohort establishment, regular
assessments, intervention trials, and measurement refinement, the project aims to significantly improve clinical
strategies for combatting muscle atrophy and its adverse consequences.

Public health relevance
The aging Veteran population has more frequent inpatient hospitalizations than non-Veteran. In addition, older Veterans have an inability to fully recover muscle mass and function after hospital-acquired weakness. The problem of hospital-acquired weakness is greatly increased in at-risk Veteran populations such as those with chronic kidney disease (CKD). The purpose of this collaborative study involving Denver and Baltimore VAMC sites is to improve health through the detection and rehabilitation management of hospital-acquired weakness in those with CKD. The study goals include identifying and monitoring the optimal muscle assessment sites in clinical settings, examining how muscle health impacts length of hospital stay and physical resilience, and determining how home-based and supervised exercise comparatively addresses post-hospitalization physical resilience using performance tests and Veteran feedback.